TRIBAL HOME VISITING EVALUATION INSTITUTE

The Tribal Evaluation Institute (TEI) provides technical assistance, leadership, and support to promote excellence in community-based research and evaluation of Maternal, Infant, and Early Childhood Home Visiting (MIECHV) initiatives that serve American Indian and Alaska Native (AI/AN) children and families through the Tribal Maternal, Infant, and Early Childhood Home Visiting program. Example focal areas of technical assistance to grantees include: developing and implementing a rigorous evaluation of home visiting; selecting, adapting, and developing culturally appropriate data collection tools and measures; tracking and measuring benchmarks; developing and modifying existing data systems; continuous quality improvement; data protection and privacy; and ethical dissemination and translation of evaluation findings derived from research with AI/AN to external audiences. Additionally, TEI will produce design options for a customized Management Information System (MIS) for Tribal MIECHV grantees to use for performance measurement and continuous quality improvement activities.